Screening for Compounds that Lower Intracellular Alpha-Synuclein Levels

PROJECT SUMMARY/ABSTRACT
The goal of this Supplement, as with the parent grant, is to identify agents that reduce the levels and
accumulation of alpha-synuclein (αSyn) that underlies the pathogenesis of Parkinson's disease (PD). The
premise of this Supplement proposal is supported by preliminary data from the parent grant and by numerous
reports including point mutations or duplication/triplication of the SNCA (Synuclein Alpha) gene that results in
αSyn increases leading to autosomal-dominant early-onset PD. The finding that the promoter for the SNCA gene
is hypomethylated in PD resulting in increased expression and that over-expression of the gene is a factor
contributing to onset of PD suggests reducing the levels of αSyn is a promising target for therapeutic intervention.
Furthermore, reduction of αSyn levels using agents such as β2-adrenoreceptor (β2AR) agonists has been
reported to be neuroprotective in both cell line and rodent models. An epidemiological analysis of a Norwegian
population revealed individuals using β2AR agonist, salbutamol for asthma, have a reduced risk of developing
PD. In this Supplement, as part of expansion of the aim 1, we will evaluate the effect of validated hits on αSyn
oligomerization and formation of intracellular aggregates using the bimolecular fluorescence complementation
(BiFC) assay. Such inhibitors could reduce intracellular αSyn levels by downstream effects enhancing αSyn
degradation. The Lewy-related pathology (LRP), primarily comprised of αSyn, is not restricted to PD and has
been found in a subset of autopsied Alzheimer's disease (AD) brains and brains of Dementia with Lewy Bodies
(DLB) patients. Apolipoprotein E4, a risk factor for AD, is also a risk factor for PD and is associated with earlier
onset of PD. A recent study also suggests there is a link between higher levels of αSyn in the CSF and early
stages of development of cognitive decline in AD. In this Supplement as part of expansion of the aim 3 we will
evaluate prioritized hits in iPSC derived neurons for effect on AD biomarkers. Current therapeutics for PD
provide only symptomatic relief, there is an urgent need for the development of disease-modifying compounds
capable of slowing or halting PD progression. To address this need in PD as well as LRP in AD and DLB, in the
parent proposal we are performing high throughput screening (HTS) of the UCLA 200K compound library to
identify hits that lower intracellular αSyn levels; these hits will be validated and prioritized by potency, drug-like
properties, and brain permeability for further analysis. In this Supplement for Aim 1 Expansion, hits identified
from HTS by AlphaLISA that reduce intracellular αSyn in SK-N-MC human neuroepithelioma cells and are
validated in primary and secondary assays in the parent grant would be evaluated in αSyn oligomerization using
the BiFC assay that we will set up during the Supplement proposal. This will enable further elucidation of the
mechanism of action (MoA) of the active hits. In Aim 3 Expansion, select compounds from Aim 2 would be
evaluated in induced pluripotent stem cell (iPSC)-derived dopaminergic neurons from PD, AD, and normal
donors; we will evaluate for both αSyn levels and AD biomarkers including sAPPα, sAPPβ and Aβ42.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Parkinson's disease (PD) is one of the leading causes of motor dysfunction and the second most common age- related cause of dementia and constitutes a significant burden to patients with PD; the currently available approved therapeutics, largely comprising medications that modulate dopaminergic function, provide only symptomatic relief and do not alter disease progression. The accumulation of the neuronal protein alpha- synuclein (αSyn) is thought to underlie the pathogenesis of PD and a multitude of reported studies support the premise of this grant application to find agents that reduce levels of αSyn; in this Supplement, we will evaluate hits identified and validated from high-throughput screening (HTS) of the UCLA compound library that decrease αSyn in human neuroepithelioma SK-N-MC cells, in secondary assays including in αSyn oligomerization assay that will be done using the bimolecular fluorescence complementation (BiFC) assay as part of the expansion of aim1 of the parent grant. As part of the expansion of aim 3 we will evaluate select compounds in iPSC derived neurons for effects on both inhibition of αSyn and modulation of other AD biomarkers; the goal is to identify compounds with optimal properties that would be lead candidates for in vivo efficacy testing and may not only be effective in PD, but also in Dementia with Lewy Bodies (DLB) and Lewy-related pathology (LRP), primarily composed of αSyn, in Alzheimer's disease.